Translational Pathology Shared Resource

ABSTRACT: TRANSLATIONAL PATHOLOGY SHARED RESOURCE (TPSR)
The Sidney Kimmel Cancer Center (SKCC) Translational Pathology Shared Resource (TPSR) provides
essential histopathology, molecular pathology, and digital pathology services to members across the
consortium, supports novel cancer research through expert pathological analysis, and provides access to
fresh, frozen, and formalin-fixed paraffin-embedded (FFPE) tissue from a diverse patient population. TPSR
maintains state-of-the-art instrumentation and uses the latest histopathology techniques to conduct visual
evaluation of the morphology of human or animal tissues as well as cellular and engineered tissue/organ
samples. TPSR facilitates access to tissues banked in a College of American Pathologists (CAP)-accredited
biorepository collected from patients with cancer. TPSR provides molecular pathology services such as
immunohistochemistry (IHC) and in situ hybridization (ISH), followed by image scanning and analysis. TPSR
also offers automatic animal complete blood cell counts (CBC). Established in 2000, the TPSR has been
continuously funded by the CCSG since 2001. With more than 20 years of clinical and experimental pathology
service experience, TPSR staff counsel, train, and educate SKCC members on histopathology research
strategies, experimental design, and techniques to explore, validate, and visualize their research findings.
The TPSR is led by Co-Directors Wei Jiang, MD, PhD, and Haifeng Yang, PhD. Jiang is a senior practicing
anatomic pathologist who provides clinical and pathological expertise and overall guidance for TPSR. Yang
is a funded cancer investigator who oversees the facility’s daily operation and provides scientific consultations
to staff and TPSR users. The TPSR is in the Bluemle Life Sciences Building and is easily accessible to all
SKCC investigators via a short walk (<1 mile). The Specific Aims of TPSR are to: 1) Provide technical support
to enhance all histotechnical aspects of oncology research, 2) Provide expertise and guidance in experimental
design, analysis, and technical troubleshooting via strategic and technical consultation, training, and
education through a single port, 3) Offer full range, state-of-the-art histopathology services, and 4) Provide
access to a CAP-accredited biorepository. During the project period, the TPSR served 84 SKCC members,
74 (88.1%) of which had peer-reviewed funding, representing all four Research Programs. TPSR services
were utilized by 128 total users in 142 peer reviewed publications (average impact factor 9.97), 38 grant
applications, and 7 clinical trials.
In line with the SKCC strategic plan, IMPACT PHL, and under the guidance of the Co-Directors and advisory
boards, the TPSR has set three goals for future development: 1) Provide multiplex IHC and IF services to
maximize the amount of data acquired from individual samples, 2) Enhance image analysis services through
use of the multiplex IHC/ISH staining platform and a multi-spectral slide scanner, and 3) Acquire an automatic
TMA platform using S10 grant applications and internal Capital equipment grants to expand our TMA service.